Identifying drivers of periductal fibrosis in primary sclerosing cholangitis using single-cell analysis of patient biospecimens

PROJECT SUMMARY
Primary sclerosing cholangitis (PSC) is a chronic inflammatory condition of the biliary epithelium characterized
by periductal fibrosis, a heightened risk for cholangiocarcinoma, and frequent comorbidity with inflammatory
bowel disease (IBD). The periductal fibrosis observed in PSC narrows the lumen of affected bile ducts and
causes extrahepatic cholestasis, which mediates further liver injury. PSC patients typically develop end-stage
liver disease within 10-20 years of diagnosis, making PSC a clinically significant cause of liver transplant in the
United States. There are currently no disease modifying drugs for PSC, underscoring the unmet need for novel
research that characterizes the pathologic mechanisms that drive periductal fibrosis in PSC patients.
Aim 1 seeks to dissect the cellular heterogeneity of the periductal niche and characterize cell subpopulations
mediating periductal fibrosis in PSC patients using single-cell multiomics. In this aim, the 10X Genomics Next
GEM single-cell RNA-sequencing platform will be used to perform integrative analysis of gene expression and
chromatin availability in single cells. The gene expression signatures of PSC patient tissue and PBMCs will be
compared to patients with metabolic dysfunction-associated steatohepatitis (MASH) and non-cirrhotic controls.
Aim 2 seeks to map the spatial organization of cell subpopulations within PSC periductal lesions and reveal
cellular interactions within intact tissue. In this aim, the 10X Genomics Xenium in situ Gene Expression
Analyzer will be employed to measure the expression of 400 genes in 10µm thick, 12mm x 22mm tissue
sections produced from explanted liver tissue. This work will shed new light on the cellular landscape that
drives periductal fibrosis, biliary-type cirrhosis, which is often present in patients with advanced PSC, and
MASH cirrhosis, which is included as a control.
Aim 3 seeks to characterize the effects of a leaky biliary epithelium on macrophage function and collagen
production in the periductal niche using an in vitro model. Bile-stimulated macrophages will be characterized at
the RNA and protein level and differences in the activating potential of PSC patient bile versus control bile will
be assessed. Macrophage-fibroblast co-cultures will also be treated with bile and collagen production will be
measured using the Sircol assay. This work utilizes patient-derived bile samples and an in vitro myeloid-
stromal co-culture model to resolve luminal, myeloid, and stromal contributions to periductal fibrosis.
Mount Sinai Hospital cares for one of the largest and most diverse PSC patient populations in the United
States, and the Icahn School of Medicine home to pioneers in the field of hepatic fibrosis research. The training
plan for this fellowship takes full advantage of the academic environment at Mount Sinai, and the research
strategy combines a single-cell approach with the development of a novel cell culture model to assess cellular
drivers of periductal fibrosis. This work will characterize the cellular landscape of periductal fibrosis at a single-
cell resolution and promote the development of novel diagnostics and therapeutics for PSC patient care.

Public health relevance
PROJECT NARRATIVE Primary sclerosing cholangitis (PSC) is a chronic inflammatory condition of the biliary epithelium and a clinically relevant cause of liver transplantation in the United States. This proposal aims to characterize cellular drivers of periductal fibrosis, a characteristic histopathologic finding in PSC, using single-cell analyses of patient tissue and macrophage-fibroblast co-culture studies. This work will dissect the cellular heterogeneity of the periductal niche and characterize the cell subpopulations that mediate periductal fibrosis, which will promote the development of more effective diagnostics and therapeutics for PSC patient care.